Evaluation of the Role of Macrophage Migratory Inhibitory Factor (MIF) in mediating Stem Cell Analgesia in a Model of Orofacial Pain

Abstract/Project Summary
The effectiveness and mechanisms of stem cell-induced analgesia in treating dental pain is unknown.
We demonstrate that i.v. injections of human Stem Cells of Apical Papilla (hSCAP) reverse apical periodontitis
(infection of a tooth; AP)-induced mechanical allodynia. Moreover, hSCAP primed to periapical granulomas
(peripheral sites of tooth infection) attenuate capsaicin (CAP)-evoked intracellular Ca2+ accumulation ([Ca2+]I)
from trigeminal (TG) neurons and this effect is inhibited by anti-human macrophage migratory inhibitory factor
(MIF)-antibody (Ab). Therefore, here, we will test the central hypothesis that apical periodontitis-induced
nociceptive behaviors is reversed by hSCAP-derived release of MIF that directly inhibits TG neuronal activity.
We propose the following aims to test the central hypothesis in male and female tissues:
Specific Aim 1 will test the hypothesis that hSCAP-derived MIF inhibits TG neuronal activities in vitro
and in vivo. We will use anti-human MIF-Ab to evaluate the effect of in vivo release of MIF by hSCAP on
mechanical allodynia as well as spontaneous nociception using conditioned placed preference (CPP). Next,
using CRISPR-Cas9, we will generate a hSCAP cell line with MIF knockout. This cell line will be used to test
the hypothesis that in vitro and in vivo hSCAP-derived MIF inhibits TG neurons and AP-induced pain
behaviors.
Specific Aim 2 will test the hypothesis that neuronal CXCR4 and CD74 receptors mediate MIF-induced
inhibition of TG neuronal activity in vitro and in vivo. MIF signals via the CXCR4 and CD74 receptors
(21-23) that are expressed on mouse TG neurons (Fig. 11). We will evaluate the role of CXCR4 using
AMD3100, a small molecule CXCR4 antagonist using in vitro Ca2+-imaging and in vivo behavioral assays.
Next, we conditionally delete CXCR4 from TG sensory neurons to evaluate the function of CXCR4 receptors
in vitro and in vivo. Next, will inject mice with AVV-shRNA against CD74 via an intraganglionic route to
assess the effect of neuronal CD74 receptor knockdown on in vivo nociceptive behaviors and as well as in
vitro Ca2+-imaging.
Specific Aim 3 will determine the signaling pathway/s activated by MIF that contribute inhibition of TG
neuronal activity. Signaling via CD74/CXCR4 receptor occurs via Gi/o proteins. We demonstrate that 1)
pretreatment with pertussis toxin (PTx) completely reverses hSCAP-induced attenuation of [Ca2+]I (Fig. 15);
and 2) MIF inhibits voltage gated Ca2+ currents (VGCaC; Fig 16) that is downstream of G activation. Using
electrophysiological approaches, we will determine MIF signaling by determining Gi versus G signaling,
type of VGCC inhibited, regulation of channels/receptors commonly known to mediate mechanical and
spontaneous behaviors and finally study alternative Gi/o-mediated pathways commonly known post-MIF
activation.
These studies have high medical significance as they define a novel ligand-receptor system for treating
infection-induced pain, possibly leading to new non-opioid analgesics. Importantly, the combined use of
human hSCAP in rodent models foster mechanistic research and increases translational significance.
RELEVANCE: These studies aim at studying new class of non-opioid analgesics for dental pain.

Public health relevance
Project Narrative/Public Health Relevance Statement Current management of endodontic pain (NSAIDs/APAP and opioids) is associated with adverse side effects. Our study proposes to study a previously unknown mechanism of stem cell-induced analgesia via macrophage migratory inhibitory factor, in a mouse model of dental pain.